Advancing Aortic Aneurysm Strength Predictions: A Novel Density-Driven Strength Assessment Tool

Project Summary
Thoracic aortic aneurysms (TAA) are irreversible focal dilatations of the aorta. Unrepaired TAAs can lead to
death following dissection or rupture, which represent the catastrophic biomechanical failure of the aneurysm
where the pressure-induced wall stress surpasses the wall strength. Reliable assessment of both the wall
strength and wall stress in patient-specific TAA could be a powerful tool for predicting TAA failure and, hence,
assessing rupture or dissection potential. As a TAA progresses, the stress acting on it generally increases, and
the wall strength decreases due to breakdown and damage to the extracellular matrix. While non-invasive
estimation of wall stress in TAA through computational finite element analysis and, more recently, artificial
intelligence is well-established, accurate non-invasive assessment of tissue strength for direct comparison to
stress has been elusive.
Studies have established the tensile strength of TAA as a general population compared to non-aneurysmal
aorta, and between different cohorts of patient pathologies or demographics. However, to date, no means of
estimation of the tensile strength for individual (patient-specific) TAA exists, nor does the ability to predict
spatial distribution of tissue strength within a given TAA.
We recently introduced and validated the concept of the tensile strength of porcine aortic tissue being directly
related to its tissue mass density. This proposal aims to extend this concept to human TAA tissue and utilize
state-of-the-art imaging to estimate tissue mass density. Specifically, we will conduct the following specific
aims:
Aim 1A) Assess the ability of bulk tissue density to serve as a predictor of local tissue strength in human TAA;
Aim 1B) Evaluate the viability of diffusion tensor magnetic resonance imaging (DT MRI) for measuring local
TAA tissue density; and
Aim 2) Demonstrate that regions of reduced tissue mass density in TAA tissue coincide with regions of tissue
weakness and, subsequently, with the initiation of biomechanical tissue failure. This aim will also provide novel
information on TAA tissue failure by using high-speed imaging of tissue specimens under loading until failure.
Our multidisciplinary team will address this critical gap in TAA patient management using innovative and novel
methods. If successful, the proposed work can lead to a paradigm-shifting tool for the estimation of patient-
specific TAA tissue strength distribution for direct comparison to companion wall stress distribution maps. By
evaluating both strength and stress distributions we may identify not only which TAA patients are prone to
rupture or dissection, but where that failure might occur in their aneurysm.

Public health relevance
Project Narrative Thoracic aortic aneurysm (TAA) is the balloon-like enlargement of the aorta over time, resulting in areas of local weakness that can lead to the aorta tearing or bursting. Clinicians currently try to predict which patients are in danger of this occurring by evaluating the diameter of the aneurysm, though this one-size-fits-all method is not reliable. The proposed research will investigate the use of imaging to better determine which aneurysms are weak enough to be considered in danger, which could allow for better patient assignment for surgery.